Biological Science Program at The Gerontological Society of America's 2024 Annual Scientific Meeting

PROJECT SUMMARY
This proposal requests funding from the National Institute on Aging for the Biological Sciences (BS) Section
Program at the 2024 Annual Scientific Meeting (ASM) of the Gerontological Society of America (GSA) in Seattle,
WA. Our aim for BS programming is to highlight the highest-quality aging research with a focus on Harnessing
the Hallmarks of Aging. We believe that the best work in the field will emerge when basic researchers
exchange information about health-related biology of aging with medical researchers and practitioners,
psychologists, sociologists, and public policy experts. In turn, improvements in clinical care and public health are
likely to result when gerontologists from diverse disciplines better understand basic mechanisms of aging and
are exposed to the latest and best research with the promise of yielding interventions to ameliorate aging and
age-related disease. We in the BS Section take our responsibility to expose our members, those of the Biological
Sciences and the GSA at large, to well-communicated, cutting-edge science that ultimately serves to inform and
improve the work of all who attend, very seriously. The ASM is situated uniquely in the U.S. to promote an
interdisciplinary effort of this scope, and the 2024 November meeting in Seattle will provide an outstanding
opportunity to expand the diversity of participating scientists. The BS Section has demonstrated quantifiable
success in producing a scientific program of the highest possible quality and providing a forum to engender
interaction and exchange of ideas among scientists from diverse fields. In November 2024, we propose to
intensify and extend our efforts, through a single-track meeting program featuring emerging concepts in the basic
biology of aging; to promote discussion and networking among attendees across sections; to enact gender
balance and diversity in the oral program; and to feature talented early career investigators prominently in
Biological Sciences symposia. In Seattle, we will begin with the National Institute on Aging, Division of Aging
Biology sponsored pre-meeting, two half-day workshops organized by Max Guo and Tiziana Cogliati and Fei
Wang. During the main meeting 14 (non-competing) oral sessions will be held. These sessions were devised by
a team of ten Investigators recruited for their expertise and as leaders in aging research. Each member of the
team will Chair a session and will participate in all aspects of the meeting organization, evaluation, and student
engagement, under the mentorship of PI LeBrasseur. There will also be two poster sessions scheduled so as
not to compete with any talks. Along with GSA leadership, we have devised strategies to recruit
underrepresented scientists and support 8 minority scholar travel awards. Our program shows 31% of all
speakers are Early-Stage Investigators, 42% of the invited speakers are women, and 29% are from
underrepresented minority groups.

Public health relevance
PROJECT NARRATIVE The Biology of Aging program at the Gerontological Society of America (GSA) 2024 Seattle meeting is organized in accordance with the GSA’s mission to promote interactions between biologists and other scientists of diverse disciplines focused on aging, age-related disease and disability; and the social, psychological, and public policy impacts of an aging society. The goals of the Biology of Aging program are to (1) present cutting-edge advances in biology of aging research that provide new avenues for translation to human well-being and extension of healthy human lifespan and (2) to expand the diversity of scientists actively participating in biology of aging research. Our program shows that 31% of our speakers are early-stage investigators, 42% are women, and 29% are from underrepresented minority groups.